Advanced thin-slab TOF-PET detector module for next generation of brain PET

ABSTRACT (30 lines)
It is well established that the increasing lifespan in the US is leading to increased prevalence of brain diseases
and mental illnesses, with dementia and Alzheimer’s posing significant challenges to the healthcare system.
Because brain Positron Emission Tomography (PET) is a powerful noninvasive tool for clinical studies and
research on fundamental mechanisms of brain maladies and metal disorders, it is expected to play an
important role in addressing this challenge. However, current brain PET technologies are limited with relatively
low sensitivity and low spatial resolution, constraining its usefulness in this context. Consequently, there is a
critical need to improve quantitative imaging performance of brain PET. To address this need, we propose to
develop advanced detector modules and associated algorithms, leveraging in particular recent progress in
time-of-flight (TOF) detector technologies. These modules will lay the foundation for a follow-on project to
develop an ultra-high-performance dedicated whole-brain TOF-PET camera (BRAIN PET EXPLORER) for
research and clinical work. This device will overcome the current technology shortcomings by providing
substantial gain in effective sensitivity and much higher spatial resolution imaging over the most current
advanced brain PET system (NeuroEXPLORER commissioned in 2022). The crucial factor for improved
performance of TOF-PET is better coincidence time resolution (CTR - time difference between arrival of the
two annihilation photons) enabling accurate localization of the annihilation event a line-of-response. Our
research is innovative because the goal of this proof-of-concept proposal is to build and demonstrate these
novel and advanced thin-slab TOF-PET detector modules, and establish their suitability for scale up in a full
BRAIN PET EXPLORER (future work). These detector modules will establish CTR <100 ps FWHM performance,
enabling an 8× gain in effective sensitivity and outstanding 3D event localization (compared to the current
state-of-art scanners) at reduced cost. An additional factor of up to 2× boost in effective sensitivity is expected
to be achieved by accurate determination of the point-of-first-interaction for annihilation photons that undergo
Compton scatter between detector blocks. The overall > 8× increase in the effective sensitivity can be used to
reduce the activity of radiotracer administered to the patient, reduce the examination duration, increase spatial
resolution, or increase the temporal resolution in dynamic brain-PET imaging. All these factors will make the
brain-PET a more useful, cost-effective and affordable research and clinical tool. The advent of such innovative
brain PET technology will help address growing prevalence of brain diseases and mental illnesses facing the
aging population of the US.
2

Public health relevance
NARRATIVE At present, diseases of the brain are the leading cause of disabilities and, due to longer lifespans and an increasing elderly population, these diseases are expected to become the dominant cause of death in the next 10-20 years, exceeding cancer and heart diseases. To meet this critical need, we are developing a innovative ultrahigh-performance brain positron emission tomography (PET) detector modules that will overcome current technological shortcomings and will provide advanced tools to accelerate research on fundamental mechanisms of brain maladies, and ultimately provide a valuable clinical diagnostic device. This proposed research is relevant to both public health and the NIH's mission pertaining to the development of fundamental knowledge for improving the diagnosis, staging, and treatment of brain diseases and mental illnesses. 1